Mentoring Translational Researchers in Louisiana

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To generate data/new insights?into the therapeutic efficacy of cancer- specific T cells engineered to secrete/express the TLR to facilitate translation to the patient population.